Role of Long Non-coding RNAs in the Ovulatory Process

TITLE: Role of Long non-coding RNAs in the Ovulatory Process.
ABSTRACT
Women’s reproductive health plays a pivotal role in regulating overall well-being. Unfortunately, about 12%
of reproductive-age women experience infertility. One of the most common causes of infertility is anovulation or
oligo-ovulation, supporting the paramount role of the ovulatory process in female reproductive success. Although
a few key ovulatory mediators induced by LH have been established, new and innovative research techniques
continue to discover new players in the ovulatory process. Using RNA sequencing, we have identified several
long non-coding RNAs (lncRNAs, transcripts >200 nucleotides) that are regulated during the periovulatory period
in mouse granulosa cells. In past, these lncRNAs were considered as junk DNA and believed to be transcriptional
noise and functionless. But, in recent years, evidence has accumulated showing that lncRNAs are widely
expressed, are tissue-specific, and have key roles in gene regulation by interacting with DNA, RNA, and proteins.
However, the role of lncRNAs in the ovary and specifically the ovulatory process has not been well explored.
From our novel RNA sequencing data, we have found 10 lncRNAs transcripts that are increased in granulosa
cells collected at 4h and 12h after human chorionic gonadotropin (hCG: LH analog) administration. Amongst
these 10 lncRNAs, Gm12648, a 656-nucleotide lncRNA was the most highly induced by hCG (160-fold).
Although very little is known about Gm12648, it is located directly upstream of cyclin dependent kinase inhibitor
2A which encodes the cell-cycle inhibitor p16 in the mouse. Moreover, the RNA-RNA interactome shows that
Gm12648 can interact with transcription factors (TFs) that are essential during the ovulatory process. Thus, it is
possible that Gm12648 may exert some regulatory control of genes and TFs and thereby possibly contribute to
ovarian cell fate during the periovulatory period. Similarly, other hCG upregulated lncRNAs could also exert their
regulatory role on adjacent protein-coding genes. Thus, our goal is to identify the top 5 most highly LH/hCG-
regulated candidate lncRNAs and investigate the function of these lncRNAs in the ovary, specifically their role
in the ovulatory process. To achieve our goal, mouse ovaries, granulosa cells, and COCs collected across the
periovulatory period will be utilized to characterize the expression of lncRNAs that were discovered in our
preliminary study (Aim 1), determine the target genes of Gm12648 in the granulosa cells using a RNA-seq and
RNA-RNA interaction assay approach after knocking down the expression of Gm12648 (Aim 2), and begin to
elucidate the function of Gm12648 by characterizing the proteins coded by the target genes, and identify post-
translational modifications such as phosphorylation, acetylation, methylation, and ubiquitination (Aim 3) in the
ovulation process. We will use a high-impact, translational mouse model in this study. The proposed project will
lay a foundation for future studies examining lncRNA function in the human ovary. These discoveries will further
improve our understanding of the ovulatory process which provides a fundamental platform to improve infertility
treatments and/or to develop the contraceptive measures that specifically target ovulation inhibition.

Public health relevance
NARRATIVE The present study explores the role of long non-coding RNAs (lncRNAs) in the ovulatory process. We have discovered a number of lncRNA transcripts that were highly regulated by hCG (LH-analog) prior to ovulation in mice, however, nothing is known about their function in the ovulatory process. Hence, the proposed studies will investigate the role of the most highly LH/hCG-regulated ovarian lncRNAs associated with the processes of follicular rupture and oocyte release, which will aid in the understanding of the regulation of human fertility.